Cancer Research Training and Education Coordination

Cancer Research Training and Education Coordination: Summary/Abstract
The mission of HDFCCC Cancer Research Training and Education Coordination (CRTEC) is to provide
exceptional cancer research training and education across the learner continuum in alignment with the
HDFCCC mission. CRTEC activities are intended to foster the development of a robust, diverse network of
transdisciplinary researchers and healthcare professionals, and represents a foundational principle of the
Center that is integrated throughout the HDFCCC. CRTEC ensures that current and future learners are trained
to contribute to the Center’s cross-cutting themes of Impactful Discovery (Theme 1); Effective Translation
(Theme 2); and Implementation and Dissemination (Theme 3). To accomplish these goals, CRTEC (1) delivers
high-quality cancer-related education and mentoring activities across the training continuum; (2) promotes and
supports diversity, equity, inclusion, and accessibility in cancer research training and education; and (3)
integrates training and education across the HDFCCC.